Regulation of Tendon Repair with Stem Cell-Derived Extracellular Vesicles

PROJECT SUMMARY/ABSTRACT
Tendon and ligament injuries are among the most common and challenging orthopedic conditions. Many patients
suffer from long-term pain and reduced function after injury. Substantial evidence indicates that these
unsatisfactory outcomes result primarily from an imbalanced healing response with excessive and/or sustained
inflammation and inadequate tendon regeneration. We discovered that extracellular vesicles produced by
inflammation-primed adipose-derived stem cells (iEV) could potentially restore balanced healing by attenuating
inflammation mediated by macrophages and stimulating regeneration driven by tendon cells. However, bulk iEV
are heterogeneous. Differentially generated iEV carry different mRNA and microRNA molecules, which
determine iEV functions. There is strong evidence that only a fraction of iEV carry the active molecules that
balance the injury responses of macrophages and tendon cells, whereas many other iEV could potentially
compromise tendon healing or cause unwanted side effects. Therefore, it is necessary to identify the iEV
subpopulation and active cargo molecules specific for tendon repair and use them to develop disease-specific
therapy to greatly enhance tendon repair. To achieve this goal, bulk iEV will be sorted into hierarchically
organized subgroups based on vesicle generation and cargo sorting machineries that determine vesicle cargo
composition. The subpopulation and active cargo molecules that specifically enhance tendon healing will be
identified by their potency in regulating tendon cell and macrophage activities and functions. The therapeutic
efficacy of identified iEV and cargo molecules for tendon repair will be examined in a preclinical mouse Achilles
tendon injury and repair model. We anticipate that removal of functionally non-specific iEV or selective
enrichment of functionally specific cargo molecules in bulk iEV will greatly increase the therapeutic efficacy and
avoid potential adverse side effects of bulk iEV for tendon injury treatments. This study is a critical proof-of-
concept analysis toward clinical application of extracellular vesicle (EV)-based therapy for tendon and ligament
injuries, which will benefit millions of patients. This study also will discover the mechanism of iEV action for
tendon injuries, and mechanisms underlying the molecular regulation of tendon cell and macrophage activities
and functions. Knowledge gained about the active molecules, surface markers, and biogenesis of the iEV
subpopulation specific for tendon repair will be used to increase the yield and release of these iEV by parent
cells and scale up iEV production via immunoaffinity-based method. Our established approaches can be used
for the future development of EV-based and disease-specific therapies for other medical conditions, which will
improve the quality of life and outcomes of more patients.

Public health relevance
PROJECT NARRATIVE Approximately 32 million individuals each year in the United States suffer from tendon injuries, and many of these injuries take long time to heal and do not heal well. There is strong evidence that some but not all the extracellular vesicles produced by adipose-derived stem cells have great potential to promote tendon healing. Accordingly, the proposed project aims to identify tendon-specific extracellular vesicles to treat tendon injuries effectively and safely.